Breast Cancer Risk prediction for Hispanic women.

This project develops a new risk prediction tool, specific to individual Hispanic subgroups, with the end goal of reducing breast cancer incidence and mortality in these populations. The work this year involved three main projects. (1) We are developing a risk prediction tool that will use population-specific data (e.g., sociodemographic data, incidence, mortality, etc.) to improve the prediction of subsequent risk of breast cancer in specific Subgroups of Hispanic women; (2) We will include a polygenic risk score as a predictor in the risk prediction model in order to improve its discrimination accuracy; (3) We are validating the predictive performance of two previously developed risk prediction models (Breast Cancer Risk Assessment Tool and Breast and Ovarian Analysis of Disease Incidences and Carrier Estimation Algorithm) in a Hispanic population of Women in the Sister Study.